QUANTITATIVE INTERROGATION OF IN-VIVO MELANOCYTIC LESIONS USING NEAR INFRARED

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The central aim of this project is to develop a novel in-vivo optical skin imaging system to quantitatively characterize changes in skin that accompany dysplastic transformation. The modulated Imaging (MI) instrument uses patterned illumination to non-invasively obtain subsurface images of biological tissues. This non-contact approach enables rapid quantitative determination of the optical properties of tissues over a wide field-of-view. When combined with multi-spectral imaging, the optical properties at several wavelengths provide quantitative measures within tissues to determine the in-vivo concentrations of chromophores, including oxy- and deoxy-hemoglobin, water, lipid and melanin. Furthermore, images at various spatial frequencies can be processed to visualize depth-sectioned subsurface features in terms of scattering and absorption.Our hypothesis is that this multi-modality MI instrument can serve as an imaging platform for quantitative characterization of benign and malignant melanocytic skin lesions.